PHASE I BIOAVAILABILITY STUDY OF INTRAVENOUS VS ORAL HYDROXYUREA

This is a phase I study to examine the bioavailability of intravenous vs oral hydroxyurea in patients with histologically confirmed advanced malignant disease.